Ethnopharmacology of medicinal plants for postpartum women's health

ABSTRACT
This study is responsive to the Notice of Special Interest (NOSI) NOT-OD-24-079 “Women’s health research”
objectives to “advance research to reduce health disparities and inequities affecting women’s health, including
those related to race, ethnicity, age, socioeconomic status, disability, and exposure to environmental factors and
contaminants that can directly affect health."
Globally, more than 250,000 women die from complications related to pregnancy and childbirth. The World
Health Organization estimates that almost 95% of these deaths occur in low- or middle-income countries, with
most fatalities considered preventable. Worldwide, many women employ traditional methods, including medicinal
plants, to support their postpartum health, particularly when biomedical healthcare is unavailable. These plants
are typically prepared as topical washes or baths to prevent infection and promote wound healing after birth.
Therefore, the phytochemicals present in these plants come into direct contact with the vagina, including
epithelial cells and beneficial or pathogenic vaginal microbes. Many of the plants used in these preparations are
globally recognized medicinal plants that are shared across cultures and geographic regions. Furthermore, these
shared plant species are often prepared in herbal mixtures with each other, along with other botanical ingredients,
as postpartum washes. Since these plants are often combined for this purpose, they may have synergistic
properties that support their ethnobotanical use. Due to their global ethnobotanical significance, there is an
urgent need to assess these plants and traditional preparations for their efficacy and safety concerning
postpartum women’s health. While the prioritized species from our preliminary data are generally well-studied
medicinal plants, they have not been investigated, alone or in herbal mixtures, for their effects on vaginal
epithelial cells and common puerperal pathogens such as Gardnerella vaginalis and Streptococcus spp.
In this proposal, we aim to evaluate plants and popular traditional preparations for their impact on the vaginal
ecosystem, including vaginal bacteria and epithelial cells. We hypothesize that the medicinal plants used in
postpartum herbal washes contain bioactive compounds that support their traditional use for postpartum
recovery. To accomplish these goals, we propose the following specific aims: 1) Assess the in vitro effects of
popular medicinal plants on postpartum women’s health; 2) Assess the synergistic effects of traditional herbal
mixtures on postpartum women’s health. Both aims will implement cutting-edge analytical techniques and data
processing methods, such as interaction metabolomics, and microED for the structural elucidation of bioactive
compounds. We anticipate that these studies will provide objective, evidence-based information on popular
medicinal plants and herbal preparations in the context of postpartum women’s health and build upon my
foundation as an independent researcher, aiming to advance public health in marginalized communities.

Public health relevance
PROJECT NARRATIVE Cultures worldwide use medicinal plants to support postpartum health, but few have been scientifically studied for safety, effectiveness, or chemistry. This project focuses on research training to evaluate commonly used postpartum plants, providing better guidance for women using these remedies globally.